CXCL12 signaling axis in pulmonary arterial heterogeneity, development, and disease

PROJECT SUMMARY
Reengagement of developmental paradigms frequently instructs disease pathogenesis. While critical for
growth and differentiation for tissue formation, aberrant expression of these pathways leads to significant
pathology such as cancer, autoimmunity, and chronic disease. Similarly, disruption of normal fetal programs in
the lung can result in significant pulmonary vascular hypoplasia during development and loss of homeostasis in
the adult, suggesting a common role in prevention of disease. Thus, understanding the cellular and molecular
mechanisms orchestrating pulmonary vascular development will help identify therapeutic targets for lung disease
To investigate the cellular and molecular pathways driving development, we focused on the arterial
endothelium, a vascular compartment important in the regulation of vascular resistance and prevention of lung
diseases such pulmonary hypertension (PH). We labeled arterial endothelial cells (ECs) using the Cxcl12DsRed
fluorescent reporter mouse in which a red fluorescent protein is produced in cells expressing the hallmark arterial
gene, Cxcl12. We isolated Cxcl12+ cells and performed single cell RNA sequencing to assess cellular
heterogeneity within the pulmonary endothelium. Combined cell annotation, gene ontology analysis, and spatial
transcriptomics revealed spatially and functionally distinct novel subpopulations of arterial ECs in the developing
lung. In addition, we discovered a CXCL12 morphogen gradient from arteries to capillaries, suggesting a
haptotaxis mechanism to pulmonary artery growth. Furthermore, disruption of the morphogen gradient resulted
in pulmonary vascular hypoplasia and aberrant branching that we quantified by applying unique methods for the
lung.
In this proposal, we are assessing an expanded role for CXCL12 in development and disease. Spatial
transcriptomics for Cxcl12 and its receptors, Cxcr4 and Ackr3, promote our hypothesis that arterial growth
and assembly is governed by a CXCL12 morphogen gradient directing cell migration of capillary
progenitor cells to the distal artery. In addition, this pattern of expression is observed into adulthood, and we
hypothesize that the pulmonary arterial tree contains spatially and functionally distinct subpopulations
conserved throughout the lifespan. We will test these hypotheses using genetic mouse models and single
cell technology to uncover mechanisms of arterial heterogeneity and CXCL12-orchestrated pulmonary vascular
development.
Aim 1. To define the spatiotemporal role of CXCL12 signaling in pulmonary vascular development.
Aim 2. To assess CXCL12-dependent EC heterogeneity and signaling in developmental lung disease.
Aim 3. To identify and characterize evolutionarily conserved proximal and distal arterial ECs.

Public health relevance
PROJECT NARRATIVE Disruption of normal development and loss of homeostasis lead to significant pulmonary vascular hypoplasia and pulmonary hypertension (PH). Repair and regeneration of the lung vasculature can be directed by re- engagement of developmental paradigms and pathways. As such, we are studying the role of a classic angiogenesis pathway, CXCL12 signaling, in pulmonary vascular development and repair and how its expression establishes arterial heterogeneity and repair mechanisms across the mammalian lifespan.